BIOLOGICAL EMBEDDING OF SOCIAL DISADVANTAGE IN HUMAN STEM CELLS: IMPLICATIONS FOR HEALTH DISPARITIES

ABSTRACT
Exposure to social disadvantage is the most salient determinant of population health disparities. Although sub-
stantial progress had been made in understanding how social disadvantage becomes biologically embedded, crucial
knowledge gaps remain. Biological embedding has been described primarily at the level of differentiated cell types and
tissues. Based on the consideration that a) social disadvantage’s long-term effects extend well beyond the lifespan of
differentiated cells, whose replenishment occurs only from stem/progenitor cells, and b) can be perpetuated across
generations, we advance the novel hypothesis that the origins of health disparities may extend all the way down to the level
of stem cells, and specifically to the effects of maternal social disadvantage exposure on offspring stem cells during
embryonic/fetal life. Our proposed study will focus on disparities between Hispanic, non-Hispanic Black, and non-Hispanic
White mothers and their newborns in obesity and metabolic phenotypes; on mesenchymal progenitor/stromal cells (MSCs) and MSC-
derived adipocytes as the stem and differentiated cells of interest; on mitochondrial function, adipogenic propensity/activity and
insulin sensitivity as the key intracellular processes of importance; on newborn adipose tissue mass and glucose-insulin regulation
as the outcomes of significance; and on maternal-fetal gestational biology as the proximate transmission pathway. We will
conduct this study in a cohort of N=240 child-mother dyads; isolate and culture fetal MSCs from newborn cord
tissue; perform high-resolution cellular experiments; and characterize neonatal phenotypes in vitro in MSC-derived
adipoctyes, and in vivo using whole body densitometry. Aim 1 will test the hypothesis that maternal exposure to social
disadvantage is associated with newborn mesenchymal stem cell characteristics, i.e., reduced mitochondrial efficiency,
increased adipogenic propensity, and reduced insulin sensitivity. Aim 2 will test the hypothesis that variation in ma-
ternal and fetal gestational biology (composite measures of endocrine, immune/inflammatory, and metabolic ligands)
mediates the effects of social disadvantage on newborn mesenchymal stem cells. Aim 3 will establish the clinical
significance of variation in MSC characteristics for neonatal obesity-related phenotypes at the a) cellular level (MSC-
derived adipocyte size and fat content; mitochondrial function; adipogenic activity), and b) whole-body level (percent
fat mass and systemic insulin sensitivity). Aim 4 (exploratory) will elucidate potentially modifiable maternal psychosocial
and behavioral factors that relate to the specific components of social disadvantage that are associated with new-
born MSC biology. Aim 5 will establish a shared repository (biobank) of MSC, cord blood, cord and placental tissue
samples for future studies of molecular mechanisms (gene expression profiles, epigenetic characteristics) and in vitro cell
differentiation analyses. Significance and impact: 1) Our study will define novel measures (with norms) in human
newborn stem cells that profile the earliest vulnerabilities for health and population health disparities; 2) broaden
understanding of novel cellular targets and molecular mechanisms underlying biological embedding of social disad-
vantage, that, in turn, may inform risk identification, prevention, early diagnosis, and personalized intervention; and
3) provide a unique and valuable shared resource (human newborn stem cell culture biobank).

Public health relevance
PROJECT NARRATIVE Exposure to social disadvantage represents the most salient determinant of population health disparities in our nation. Our goal is to better understand the phenomenon of biological embedding of social disadvantage in the con- text of health and health disparities in obesity and metabolic outcomes. We hypothesize that the effects of social disadvantage may extend all the way down to the level of stem/progenitor cells – the cells that continually replenish our tissues and organ systems. In a study of Hispanic, non-Hispanic Black, and non-Hispanic White mother-child dyads, our project will test this hypothesis in stem cells obtained from child tissues (umbilical cord) at the time of birth. We will measure cellular features of child mesenchymal stem/progenitor cells (MSCs) and MSC-derived fat cells, along with newborn fat mass and glucose-insulin physiology. We expect our study findings to suggest avenues to better optimize long-term health and well-being.